Multi-omic Studies of Local and Systemic Immune Dysregulation in Rosacea

Project Summary/Abstract
Our research proposes to elucidate local and systemic immune dysregulation in rosacea with the long-term goals
of developing novel preventative and therapeutic targets and improving overall health outcomes for rosacea
patients. Rosacea is a common inflammatory skin disease with unclear etiology affecting over 14 million people
in the United States alone.1 Toll-like receptor 2 (TLR2) is a microbe-sensing mechanism that maintains immune
homeostasis in the skin through communication with commensal microbes.2-4 Therefore, we suspect that
understanding the skin microbiota-host interaction is critical to elucidating the pathogenesis of rosacea. Moreover,
the immune dysregulation in rosacea does not appear to be localized to the skin. There is a growing body of
epidemiological evidence demonstrating that rosacea is associated with a wide range of systemic co-
morbidities.40-51 Thus, it is also important to elucidate potential systemic immune dysregulation that can explain
the overall disease burden in rosacea patients. Aim 1: We aim to test the hypothesis that skin dysbiosis induces
transcription and expression of the components of the innate immune response implicated in the pathogenesis
of rosacea. To that end, we will perform multi-omics data integration of the microbiome, transcriptome, and
proteome from rosacea skin in order to delineate the microbiota-host interaction. Aim 2: We aim to test the
hypothesis that there is shared immune dysregulation between the skin and systemic circulation that can explain
the burden of systemic co-morbidities in rosacea patients. To that end, we will perform multi-omics data
integration of the transcriptome and proteome from the skin and blood/serum in order to characterize shared
molecular pathways. Dr. McGee’s career goal is to become a physician scientist with the unique expertise to
apply multi-omics, data-driven, personalized strategies to treat inflammatory skin diseases and their associated
systemic co-morbidities. To achieve this goal, she will undertake a combination of formalized coursework,
workshops, and hands-on training in bioinformatics, computational biology, human subjects research, and
clinical trials. She will also engage in career development activities by participating in a grant writing course and
a K-R transition program. Dr. McGee’s research and career development will be guided by a mentoring team
with several decades of combined experience in successfully transitioning their mentees to research
independence. Dr. McGee’s training will take place at two prominent academic institutions: 1) Beth Israel
Deaconess Medical Center, a major teaching hospital of Harvard Medical School which supports ~250 principal
investigators and offers 16 institutional and 12 departmental core facilities, and 2) Harvard T.H. Chan School of
Public Health, which hosts the consistently ranked #1 biostatistics program in the country and supports
computational research initiatives to answer multidisciplinary questions.

Public health relevance
Project Narrative The goals of our research are to 1) elucidate the mechanistic link between skin microbiota and local immune dysregulation in rosacea skin and 2) elucidate potential systemic immune dysregulation in rosacea patients. Unlike prior studies, we aim to employ multi-omics data integration to 1) explain the complex relationship of the microbial environment and the host immune response in the skin, and 2) characterize the systemic immune dysregulation that can explain the systemic disease burden in rosacea patients. We anticipate that our findings will lead to the development of novel preventative and therapeutic targets and shift the way we study and manage rosacea toward early detection and prevention of systemic co-morbidities.